Photoreceptor patterning in flies and mosquitoes

Project Summary: During development, sensory neurons differentiate into subtypes with distinct morphologies,
gene expression, and functions. In the retina, the diversity of photoreceptor subtypes is critical for vision and the
ability to interact with the environment. This proposal aims to advance our knowledge of cell fate specification
by examining how photoreceptors are patterned during development in flies and mosquitoes.
In the fly eye, stereotypical and stochastic patterns are overlaid during development. The stereotypical
structure of the eye results from a wave of morphogenesis, driven by Hedgehog (Hh) signaling, which promotes
expression of Decapentaplegic (Dpp). Overlaid on the regular morphology of the eye, two R7 photoreceptor
subtypes are stochastically patterned, controlled by stochastic ON/OFF expression of the transcription factor,
Spineless (Ss). My preliminary studies show that Hh signaling coordinates stereotyped and stochastic patterning
in the fly eye, requiring activity of the receptor Patched (Ptc), but not Cubitus Interruptus (Ci), the canonical
transcriptional effector. I hypothesize that Hh functions through an unidentified transcriptional factor to promote
(1) dpp transcription and stereotypical morphological patterning and (2) ss transcription and stochastic R7
subtype patterning. To test this hypothesis in Aim 1, I will analyze the transcriptional and chromatin dynamics of
dpp and ss regulation. I will generate a single-nucleus multiomics dataset to identify putative transcription factors
mediating Hh signaling and examine their functions in the eye. This aim will address how signaling mechanisms
that drive stereotypical patterning are co-opted to produce stochastic patterns during development.
Mosquitoes are a disease vector that pose an increasing risk to human health and welfare. In mosquitoes,
vision is critical for host-seeking, mating, and foraging behaviors, yet the mechanisms that establish patterning
of the mosquito eye are not known. In contrast to the fly eye, R7 subtypes are found in stereotypical stripe
patterns in the dorsal and ventral regions of the mosquito retina. I hypothesize that the gene network giving rise
to stereotypical PR subtype specification is vital for mosquito survival behaviors. To test this hypothesis in Aim
2, I will generate a single-nucleus multiomics atlas of retinal development in An. gambiae, identify factors with
cell-type-specific expression and roles in fly eye development, and validate their expression using IHC and RNA
FISH. I will determine roles for Drosophila R7 patterning genes in An. gambiae. Finally, I will determine the
functional roles of R7 subtype specification in behavior using host-seeking assays. In my lab, I will dissect the
regulatory networks involved in mosquito retinal development, focusing on patterning and cell fate specification.
Using the atlas, I will define the roles of ~30 key regulators previously characterized in flies, and compare their
functions across species, including Ae. aegypti. I will also identify and test novel regulators of mosquito eye
development. These studies will provide the first mechanistic dissection of eye development in mosquitoes,
generate insights into evolution of the underlying mechanisms, and establish my independent research program.

Public health relevance
Project Narrative During development, sensory neurons differentiate into subtypes with distinct morphologies, gene expression profiles, and functions. In this project, I propose to determine how stochastic and stereotypical patterning of photoreceptors is coordinated in the fly eye and describe how the regular patterning of photoreceptors is achieved in the mosquito eye. This project will provide fundamental mechanistic insights into photoreceptor patterning and the first analysis of retinal developmental in mosquitoes, a disease vector that impacts human health globally.